Molecular Analysis of Nuclear Pore Complex Function

DESCRIPTION (provided by applicant): Controlled exchange of protein and RNA between the nucleus and cytoplasm is a process of fundamental importance to all eukaryotic cells and essential for proper gene expression. One of the most outstanding questions in the nuclear transport field involves delineating how messenger RNAs (mRNAs) are exported through nuclear pore complexes (NPCs) embedded in the nuclear envelope. It is also unclear how the mRNA export mechanism is connected to translation regulation. The long-term goal of this project is to elucidate the molecular sequence of events required for coupling mRNA cargo translocation through NPCs to cytoplasmic mRNA trafficking and translation. We hypothesize that key events for mRNA export directionality are controlled at the NPC by the action of multiple factors. We further speculate that some of the NPC associated factors are multi-functional and effectively link the export and cytoplasmic translation steps. To test these hypotheses, we propose three specific aims. In aims one and two, we will use the S. cerevisiae model to study this highly conserved machinery. In aim one, we will define the mechanism by which mRNA cargo translocates through the NPC. This involves direct interactions between the mRNA transport receptor Mex67-Mtr2 and critical binding sites in NPC proteins termed FG repeats. A panel of novel FG repeat mutants will be used to investigate the precise requirements for NPC translocation. A combination of genetic, microscopy and biochemistry approaches will be used to define key events at the NPC cytoplasmic face. We will determine how the essential mRNA export factor Gle1 and inositol hexakisphosphate (IP6) activate the DEAD-box protein Dbp5 for targeted changes in the mRNA-protein complex and directional export. The second aim will investigate how mRNA export and translation initiation/termination are functionally linked by the actions of Gle1, IP6, and Dbp5. We will generate allele specific gle1 mutants, and test for Dbp5-mediated remodeling of translation termination complexes. To reveal how translation initiation is controlled, genetic and biochemical assays will be conducted to analyze the mechanism by which Gle1 controls an initiation-specific DEAD-box protein. In aim three, we will extend these studies to mammalian cells and identify the molecular determinants for Gle1 dysfunction in disease. The mRNA export and translation perturbations will be measured for a human GLE1 mutant (gle1-FINmajor) that is causally linked to a lethal fetal motor neuron disease. Direct protein-protein interactions that are altered by the gle1-FINmajor mutant will also be identified. Together, these studies will define the machinery controlling critical steps in the mRNA life cycle, and impact our understanding of the role for altered mRNA transport and metabolism in human disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE Understanding how proteins and RNA move between the nucleus and cytoplasm will provide novel insights into the pathology of multiple human diseases. Nuclear transport factors and the trafficking mechanism are altered in some cancers and viral infections, and dysfunction induced by inherited mutations in these factors is implicated in human developmental defects, heart disease, and immune system function. These studies will also provide critical knowledge for the ultimate identification and analysis of therapeutic targets. PROJECT NARRATIVE Understanding how proteins and RNA move between the nucleus and cytoplasm will provide novel insights into the pathology of multiple human diseases. Nuclear transport factors and the trafficking mechanism are altered in some cancers and viral infections, and dysfunction induced by inherited mutations in these factors is implicated in human developmental defects, heart disease, and immune system function. These studies will also provide critical knowledge for the ultimate identification and analysis of therapeutic targets. __SpecificAimsTextDelimiter__ a. SPECIFIC AIMS Nucleocytoplasmic communication is a process of fundamental importance to all eukaryotic cells and essential for gene expression. The directional transport of proteins and RNAs between the nucleus and cytoplasm requires the aqueous channels formed by nuclear pore complexes (NPCs) embedded in the nuclear envelope. A major outstanding issue in the nuclear transport field involves delineating how messenger RNAs (mRNAs) are exported through NPCs and targeted for cytoplasmic fates. Despite great progress in defining components of the transport machinery, there remain large gaps in our knowledge regarding the mRNA export mechanism. Moreover, the extent of functional connections between mRNA export and translation is unknown. The long-range goal of this project is to elucidate the molecular sequence of events required for coupling nuclear mRNA export through NPCs to cytoplasmic mRNA trafficking and translation. This work will impact studies in multiple biological fields and the understanding of disease processes. Our proposal will analyze the mechanism and regulation of mRNA transport. We hypothesize that key events for mRNA export directionality are controlled at the NPC by the action of multiple factors. NPC translocation requires physical interaction between the mRNA export factor Mex67-Mtr2 and a family of NPC proteins that contain regions with multiple FG-type repeats (F, phenylalanine; G, glycine) separated by polar spacers. In addition, at the cytoplasmic NPC face, targeted remodeling of the messenger ribonucleoprotein particle (mRNP) composition requires Gle1 activation of the DEAD-box protein Dbp5 and soluble inositol hexakisphosphate (IP6) production. We have shown that Gle1 is an essential factor, conserved from yeast to humans, and speculate that Gle1 facilitates coupling between the export and translation steps. We are in a unique position to define these mechanisms and propose the following: Aims I and II focus on our established S. cerevisiae model, and Aim III extends to a novel mammalian cell system. Aim I: We will define the mechanism by which mRNPs translocate through the NPC. We speculate that mRNP extrusion through the NPC is dependent on a pathway of dynamic protein-protein and protein-RNA interactions. How these exit steps are controlled is not fully defined. The exact stoichiometry of Mex67-Mtr2 in the mRNP complex is also unknown. We will first examine requirements for Mex67-Mtr2/FG interactions at the NPC by using novel S. cerevisiae mutants. We will define the roles in export for FG type, repeat number and NPC locale. Second, we will investigate how Mex67-Mtr2/FG interactions link to the mechanism for mRNP remodeling by Dbp5. The order of events in the Gle1-IP6/Dbp5 cycle at the NPC cytoplasmic face will be defined using a combination of genetics, microscopy, and in vitro reconstitution assays with mutants defective in specific interactions. These studies will test hypotheses for how directionality is imposed on mRNA export and how these molecular events impact translocation through the NPC. Aim II: We will elucidate how mRNA export and translation are functionally linked. We recently discovered roles for Gle1 in both translation initiation and termination. We hypothesize that Gle1 acts independently in initiation to regulate the DEAD-box protein Ded1. However, during termination, we speculate that Gle1 acts in conjunction with Dbp5 and IP6 to remodel translationally engaged mRNPs. To investigate these translation roles, we will isolate and characterize gle1 mutants with allele specific functional defects. Using genetic and biochemical assays, we will further delineate the mechanism for Gle1 control of Ded1 during initiation. To test whether Gle1-IP6/Dbp5 mediate remodeling of termination complexes, an affinity purification strategy will be used to define differences in termination complexes isolated from mutant cells. As a complementary approach, we will examine whether Gle1 has specific mRNA targets by identifying the polysome-associated mRNAs under different mutant conditions. Together, the results will define essential steps for post-transcriptional control of gene expression. Aim III: We will identify the molecular determinants for Gle1 dysfunction in disease. Our studies of mRNA export and translation directly impact models for human Gle1 (hGle1) perturbation in pathophysiology. A recent report showed that a hGLE1 mutant (gle1-FINmajor) is causally linked to lethal congenital contracture syndrome 1 (LCCS1), a motor neuron disease. We hypothesize that gle1-FINmajor perturbs a conserved Gle1 activity. To test this, we will develop a mammalian cell culture model to analyze Gle1 knockdown phenotypes, and test the effects of adding back either wild type or mutant hGle1. Using the wealth of information from our prior studies, in vitro and in vivo assays of hGle1 function in mRNA export and translation will be completed. Further, we will conduct a differential two-hybrid screen to identify hGle1 protein partners that are specifically perturbed by the FINmajor mutant. We speculate that hGle1 plays a role in the regulating cytoplasmic mRNP trafficking and/or localized translation in polarized cells such as neurons. These studies will provide the first evidence for the molecular mechanism underlying LCCS1, and will impact the global understanding of the role for altered mRNA transport and metabolism in other human diseases.